Skeletal, Craniofacial and Oral Biology Training Grant

Project Summary:
This is a proposal for the seeking support for the Institutional Training Program in Skeletal, Craniofacial and Oral
Biology (SCOB) as a T90/R90 training program at the UConn Health, School of Dental Medicine. The SCOB
program aims to train the next generation of scientists dedicated to addressing important problems in dental,
oral, and craniofacial health through the application of state-of-the-art approaches to solve these problems. Our
program incorporates didactic, research, and career development components to prepare a diverse cadre of
individuals for productive research positions at academic, non-profit, government, biotechnology, or industry
institutions. The program has and will continue to train scholars who can initiate and maintain funded research
programs, who understand multidisciplinary research and who are prepared for the evolution of their research
programs into new directions. Areas of research training include Advanced Materials Science, Behavioral and
Social Sciences/Medicine, Cancer Biology, Computational Biology and Bioinformatics, Embryonic Stem Cell and
Mesenchymal Stem Cell, Craniofacial and Skeletal Biology, Mathematical Modeling and Imaging Techniques,
Mucosal Immunology and Microbiome and Regenerative Medicine. The major tracks of the training program are
(i) DMD/PhD (7-8 yrs of training with 3-yrs of support from this training grant), (ii) PhD (4-5 yrs of training with 3
yrs of support from this training grant, and (iii) postdoctoral research (3 yrs training and support). The
postdoctoral track supports individuals in different areas of research endeavor including Traditional post-PhD,
Post-DMD in PhD training [including non-citizen], and post-DMD involved in post-doctoral training [including noncitizen].
After a rigorous application process that culminates in personal interviews, students are enrolled
annually. To provide a solid, common foundation for our scholars/trainees, we have developed Core Activities
required of all trainees in each training track. UConn Health has a dynamic group of faculties in various areas of
research with highly successful collaborations among faculty throughout the Schools of Dental Medicine and
Medicine and The Jackson Laboratory for Genomic Medicine. The Biomedical Science PhD program graduate
faculty, active and new institutional research centers and clinical programs provide contemporary laboratory,
translational and patient oriented research opportunities that enable a diversified training environment for the
program tracks, allow flexibility for the individual needs of trainees, and ensure successful progress through the
tracks. The institution has vigorous trainee recruitment programs, with several directed towards underrepresented
minority candidates. We will continue to provide training that is tailored to each candidate through
symposia, seminars, courses, clinical research centers and collaborative research experiences.

Public health relevance
Project Narrative The goal of this training program is to prepare individuals of outstanding potential for independent research careers in dental, oral and craniofacial research. Training of these individuals is critical to the health and quality of life of the American public.